Wnt Signaling in Bronchopulmonary Dysplasia

PROJECT SUMMARY
Bronchopulmonary dysplasia (BPD) is a leading complication of preterm birth, with long term sequelae in
survivors and no curative treatment. The molecular mechanisms that promote the BPD phenotype of impaired
alveolarization and fibrosis are not known, and this knowledge gap impedes the development of new BPD
therapies. BPD primarily affects preterm infants born during the vulnerable saccular stage of lung development
(23-32 weeks gestation), with resulting injury from hyperoxia, inflammation, and mechanical stretch. Our prior
work has focused on understanding how saccular stage injury disrupts the normal patterning of developmental
pathways. One of these signaling pathways, Wnt, has peak activation in the canalicular stage and gradually
decreases during the saccular stage, with little active Wnt signaling present at term birth. We recently
demonstrated aberrant activated Wnt signaling in the lungs of infants with BPD. Moreover, exogenous
activation of Wnt signaling in our 3D human model and our hyperoxia mouse model is sufficient to reproduce
the BPD phenotype in vitro and ex vivo, suggesting that Wnt is an important driver of BPD pathogenesis.
Transforming growth factor-Beta (TGF-Beta) is another developmental pathway necessary for normal lung
development that in excess contributes to impaired alveolarization and fibrosis. Exposure of saccular stage
lung to hyperoxia injury results in increased activated Wnt and TGF-Beta signaling, and we are able to
experimentally induce TGF-Beta signaling by activation of Wnt alone. Our preliminary data show that hyperoxia
exposure of saccular stage lung results in increased mesenchymal expression of ligand Wnt5A as well as
increased epithelial expression of Wnt modulator r-spondin-3 (RSPO3), suggesting spatial specificity of Wnt
ligand expression in this model. We therefore hypothesize that that injury during the saccular stage of lung
development causes aberrant epithelial expression of RSPO3 and aberrant mesenchymal expression of
Wnt5A, and this increased Wnt signaling facilitates the activation of downstream TGF-Beta signaling, resulting in
impaired alveolarization and fibrosis seen in BPD. Our specific aims are to: 1) determine the role of Wnt
signaling in mediating impaired alveolarization and fibrosis in BPD, and 2) to identify the mechanisms whereby
hyperoxia exposure results in Wnt pathway activation and up-regulation of TGF-Beta signaling. Successful
completion of these specific aims will improve our understanding of the contribution of Wnt signaling to the
injury response in the developing lung and provide a foundation for targeted therapies to prevent BPD. Another
major objective of this proposal is to create a focused and structured career development plan that will provide
the necessary training for the researcher to become an independent physician-scientist with expertise in the
molecular mechanisms of BPD. The experiments and training program in this proposal create the structure for
the growth of an independent rigorous research program focused on developmental lung diseases.

Public health relevance
PROJECT NARRATIVE Bronchopulmonary dysplasia (BPD) is a leading complication of preterm birth, affecting more than 50% of infants born less than 32 weeks gestation, and survivors with BPD are at risk for lifelong respiratory complications. There are currently no curative therapies for this disease, and BPD accounts for $2.4 billion per year in healthcare costs and lost work productivity for patients and their families. We have identified that the Wnt signaling pathway plays a role in the pathogenesis of BPD, and this proposal seeks to understand the molecular mechanisms of how dysregulated Wnt signaling after preterm birth leads to BPD, with a goal of discovering targeted therapeutic strategies that can restore normal lung growth in preterm infants and prevent BPD.